The roles of glutathione metabolism in growth and virulence of Listeria monocytogenes

ABSTRACT
Listeria monocytogenes is a low G+C Gram-positive bacterium that can cause severe disease in
immunocompromised individuals, pregnant women, newborns, and the elderly. Pathogenic listerial strains use
a master transcriptional regulator, PrfA, to induce its most important virulence genes. In turn, the PrfA protein is
directly activated by glutathione, a cysteine-containing tripeptide, which also performs important antioxidation
and detoxification functions in bacterial and eukaryotic cells.
To reach the intracellular level of glutathione required for sufficient PrfA activation and virulence gene
expression during infection, the listerial cells need either to synthesize glutathione or import it from the cytosol
of host cells, which is rich in glutathione. Surprisingly, listerial glutathione synthesis appears to contribute more
strongly to virulence than its uptake from the eukaryotic cytosol. Glutathione uptake pathways have been
identified only in several bacterial species; the L. monocytogenes glutathione importer(s) and the reasons for
their apparent low activity during infection are not known.
To synthesize glutathione and just to grow, L. monocytogenes cells must obtain cysteine, an essential
amino acid, or a related compound from the environment. Interestingly, listerial cells can convert efficiently
exogeneous glutathione to cysteine. This glutathione degradation, depending on the yet unknown extracellular
or intracellular localization of this pathway, can reduce the metabolite level in bacterial or host cells or both.
Therefore, a tight regulation of glutathione degradation may be a critical step in listerial virulence during
infection. The glutathione-to-cysteine degradation pathway in L. monocytogenes has not been identified, and
none of the genes encoding known enzymes of glutathione cleavage are present in the listerial genome. Thus,
a novel enzyme of glutathione degradation with an unknown cellular localization is present in listerial cells.
The complete lack of information on the nature of the glutathione uptake and degradation pathways,
their regulation, and contributions to the glutathione level and PrfA activation impedes our understanding of
how virulence genes are induced under various conditions of listerial growth. We propose to fill this important
gap in our knowledge and determine the L. monocytogenes genes that are involved in the uptake and
degradation of glutathione. Expression patterns of these genes under various growth conditions will be
determined. The impact of the corresponding pathways on the glutathione listerial pool, expression of PrfA-
dependent virulence genes, and virulence in a mouse model of infection will be major targets of our research.
L. monocytogenes is one of the deadliest foodborne pathogens in the United States. This project will
allow us to identify metabolic steps required for the accumulation of glutathione at levels that are needed for
listerial virulence. In doing so, we may uncover novel pathways for potential therapeutic intervention. Similar
pathways are likely to exist in other pathogenic bacteria.

Public health relevance
NARRATIVE Listeria monocytogenes is an important bacterial pathogen that can cause severe foodborne disease in humans; the development of listerial virulence absolutely requires high levels of glutathione, an important metabolite in bacterial and animal cells. L. monocytogenes cells can import glutathione from their host cells during infection but also possess an efficient pathway of glutathione degradation; the two pathways may be critical for infection, but their identities remain unknown. We propose to identify these pathways and discover how they contribute to the maintenance of the listerial glutathione level and virulence in a mouse model of infection.